Characteristics and Function of Prefrontal Astrocyte Activity in Heroin-Seeking Behavior

Project summary/Abstract
With the current opioid epidemic at a national crisis level, understanding the neural mechanisms governing
heroin use and relapse to drug seeking is key to discovering new treatment strategies. Exposure to stimuli
previously paired with the euphoric effects of heroin are thought to maintain habitual heroin use and seeking
behaviors. These heroin-conditioned effects therefore extend the negative consequences of drug use well past
cessation. Dysregulation of the dorsal medial prefrontal cortex (dmPFC) is a driving factor in habitual heroin use
and cue-induced relapse, yet how discrete neural network components orchestrate heroin-seeking behavior
remains less clear. Using a novel head-fixed self-administration (SA) mouse behavioral paradigm and
simultaneous two-photon calcium imaging, recent data from our laboratory indicates unique excitatory neuronal
ensembles emerge and encode information related to heroin-conditioned cues and heroin-seeking behaviors.
Astrocytes are key regulatory elements in neuronal circuits and glial calcium events are necessary for modulating
neuronal network activity. However, how dmPFC astrocytes contribute to neuronal encoding of heroin-related
cues and heroin-seeking behaviors remains unknown. The goal of the current project is to investigate that
dmPFC astrocytes (1) are engaged throughout heroin use and (2) causally influence surrounding neuronal
ensemble dynamics and relapse behaviors. To this end, we will use a combination of contemporary strategies,
including in vivo two-photon imaging and chemogenetic tools, to measure and manipulate dmPFC cellular activity
during heroin use and relapse.
The current proposal will be the first to measure astrocytic calcium dynamics throughout habitual heroin use and
relapse and determine the causal influence of astrocytic activity on neuronal encoding and heroin-seeking
behavior. I propose to use a multi-virus approach and in vivo two-photon microscopy to visualize and track
individual astrocytic calcium events throughout heroin-SA, extinction, and reinstatement in head-fixed mice (Aim
1). Subsequently, I will employ two-photon imaging coupled with head-fixed heroin-SA to measure and track
neuronal activity with single-cell resolution. I will then stimulate an astrocyte-specific hM4D(Gi) designer receptor
during relapse and assess the consequence for neuronal ensemble activity and heroin-seeking behavior (Aim
2). Based on my preliminary data and published work of my mentorship team, I hypothesize that dmPFC
astrocytes display biased activation during the onset of heroin use and reinstatement of heroin seeking (Aim 1)
and that astrocytic calcium events directly coordinates surrounding neuronal network dynamics and relapse
behavior (Aim 2). These data would provide a wholistic view of how dmPFC network activity orchestrates
habitual heroin use and seeking behavior. The current proposal is the first to track astrocytic activity throughout
drug use and causally implicate glia in the neuronal encoding of drug-conditioned cues and relapse behavior.

Public health relevance
Project Narrative We will use an interdisciplinary approach to examine how the activity of prefrontal astrocytes adapts from the onset of heroin use to habitual seeking and relapse. We will determine how astrocytes incorporate into the neural network to coordinate neuronal ensemble dynamics and heroin-seeking behavior. Results will identify astrocytes as a novel cell population that can be targeted to disrupt heroin-conditioned associations, reducing relapse vulnerability in patients suffering from opioid use disorder.